Leveraging Existing Data and Analytic Methods for Health Disparities Research Related to Aging and Alzheimer's Disease and Related Dementias (ADRD)

Abstract
The continuation of a series of hybrid virtual/in-person workshops focused on progress in understanding the
causes and mechanisms of health-related disparities in Alzheimer’s disease (AD), related dementias (ADRD),
and other prominent age-related diseases to be held in 2025 and 2026 at Duke University, Durham, North
Carolina are proposed. The aim of these high-intensity workshops is to disseminate new knowledge on how
existing and recently developed analytic methods can be used in concert for detailed, reliable, and reproducible
analysis. The long-term goal of the series is to be a resource providing: the diffusion of practical methodological
know-how; applied showcasing of novel methodologies being introduced in the field; promotion of rigor and
widening the range of application of well-established methods; promotion of the correct use of big health data—
alone and in conjunction with clinical, survey, and other data resources—from a methodological, and ethical
prospective; a forum for experts and newcomers interested in health disparities and age-related diseases to
discuss their ideas, showcase their research, and receive input from experienced peers. In the planning of the
2025-2026 workshops, we will build upon the accomplishments of this series including those funded by the
parent grant of this proposal (R13AG069381). As has become customary for this series the exact schedules of
the 2025/2026 workshops will be finalized after receiving input from 2024/2025 participants. We have had great
success in using this model as evidenced by active participation of representatives of AD research centers,
minority institutions, and other methodological focus groups as well as the increasing attendance of our
workshops. The proposed 2025/2026 theme is: “Theory and Practice for Explanation of AD/ADRD Health
Disparities in Terms of Predictors”. Each workshop will contain two substantive sessions and a perspective,
methodologic, and poster session spanning the following topics in AD/ADRD and health disparities: i) methods
of artificial intelligence, ii) causal methods in the effects of risk factors, iii) advantages of mixed research, iv)
interdisciplinary research and modern infrastructural designs, v) extensions of modern methods for analyses of
multimorbidity, vi) comparison of the effects of risk factors across datasets and subpopulations, vii) emerging
topics and new challenges, and viii) genetics and the analyses of health disparities. We plan to improve the
accessibility level of the methodologic presentations by combining methodological innovations with practical
hands-on demonstrations while addressing topics of the highest interest to the audience based on feedback
gathered using pool and post-event surveys administered over the course of past Workshops. The brief, high-
intensity format brings researchers together in a single inclusive environment, pooling the available expertise
rather than diffusing focus across multiple specialized sub-sections. Coupled with our focus on rigorous
application of data/method combinations, and low barriers to participation, the culture of open academic
discussion of the Workshops provides an environment highly beneficial for new and early career investigators.

Public health relevance
Narrative Our objective is to host two hybrid virtual/in-person workshops in 2025-2026, in which research findings, evidence-based information and analytic tools for analyses of health-related disparities in Alzheimer’s disease, related dementias, and other prominent age-related diseases are comprehensively discussed. Specific Aims to be addressed in this project will be focused on increased collaboration and partnership in an interdisciplinary research community focused on analytic methods for large-scale population and clinic-related data, constructing a bridge between independent research subgroups, and the identification of ways to achieve synergistic effects in multidisciplinary research by combining innovative approaches developed across different research groups. Ultimately, our long-term goal is to diffuse the active use of advanced analytic methods for analyses of existing big health population datasets in health disparity research.